Catalytic C-C Activation of Ketones - Renewal 01

Abstract: We are engaged in the systematic efforts to exploit catalytic carbon–carbon (C−C)
bond activation for developing new, general and synthetically useful methods. Our objective, in
the proposed funding period, is to focus on C−C activation of ketones, as ketone moieties are
ubiquitously found in feedstock chemicals, synthetic building blocks and bioactive compounds.
Specifically, we will: (i) expand the scope and utilities with activation of strained ketones for
constructing complex ring systems, (ii) enable new and broadly applicable transformations with
unstrained ketones in an atom-economical fashion, and (iii) explore a new activation mode that
can shift the paradigm for ketone activation. The research proposed is expected to simplify
synthesis through new strategic bond disconnections, allow for editing skeletons of complex
molecules under redox-neutral conditions, and offer a byproduct-free approach to access
organic building blocks.

Public health relevance
Public Health Relevance Statement: Small molecules of medicinal interests generally contain carbon-carbon (C−C) bonds in their skeletons, thus methods that selectively edit specific C−C bonds are highly desirable as syntheses of biologically important compounds could be simplified or streamlined. However, broadly applicable C−C activation approaches remain largely elusive. The outlined proposal exploits several unique modes of transition-metal-mediated C−C bond activation discovered in our laboratory in developing a suite of catalytic methods that are useful for constructing complex molecules.